Validation of novel imaging and molecular tests for early detection of pancreatic cancer through risk-stratified community engagement programs

PROJECT SUMMARY / ABSTRACT
To diagnose pancreatic ductal adenocarcinoma (PDAC) in its precursor or early stages, novel screening tools
must apply liquid biomarkers with localization using novel imaging strategies in high-risk populations. The OHSU
PCDC Research Unit proposes three aims highlighting its multidisciplinary strengths in cancer biology, imaging,
and implementation science. The overarching theme of the proposed research focuses on sensitivity, feasibility,
and patient acceptability. Our sensitive blood-based screening test can be applied with minimal quantities of
blood and is easily modifiable based on further discoveries. If positive, this would prompt application of a feasible,
non-contrast, and robust magnetic resonance imaging (MRI) protocol that augments MRI and magnetic
resonance chlangiopancreatography (MRCP) of the pancreas with quantitatively rigorous MR Fingerprinting
(MRF). MRF can simultaneously quantify parameters that are associated with fibrosis and inflammation (T1, T2,
and T1p). We hypothesize that these parameters are upregulated in high-grade dysplasia (e.g., high-risk
intraductal papillary mucinous neoplasms (IPMNs) and grade 2-3 pancreatic intraepithelial neoplasia (PanIN))
and early-stage pancreatic ductal adenocarcinoma (PDAC). Further, quantitative MRI will reduce the high
interobserver variability of MR interpretation and requirement for time consuming and technically complex MR
protocols that can be challenging to implement outside of pancreas referral centers. If successful, MRF may
obviate the need for Gadolinium based contrast agents in screening populations undergoing frequent MRI and
MRCP. Finally, we will increase enrollment of high-risk individuals into PCDC Signature Cohorts, through
leveraging an existing large, statewide cohort, Healthy Oregon Project. Further, we will work collaboratively with
our Community Outreach, Research & Engagement team to understand and address barriers to engagement in
PDAC surveillance among members of minoritized communities, particularly those who suffer disproportionally
from PDAC. These efforts will ensure participation among underrepresented populations who are least likely to
take part in cancer screening while contributing to the consortium mission of expanding PCDC Signature
Cohorts.
The OHSU Research Unit is prepared to meaningfully collaborate with the PCDC Consortium by sharing
existing resources from the Oregon Pancreas Tissue Registry (> 3,700 patients enrolled), OHSU PRECEDE
consortium subjects (> 100 high-risk individuals enrolled to date) and potential expansion to other PRECEDE
centers, and the OHSU High Risk Pancreatic Cancer Screening clinic (> 750 unique patients who have
completed at least one screening test). In addition, our team includes experts in implementation science who
have designed and activated the Healthy Oregon Project, an app-based platform that allows at-home acquisition
of genetic data through mail-in kits and population-based interaction to find and interact with high-risk individuals.

Public health relevance
PROJECT NARRATIVE Screening for the early detection of pancreatic ductal adenocarcinoma and its precursors requires tests which are sensitive, feasible, and acceptable to a wide population base while easily administered outside of high- volume referral centers. The OHSU Research Unit proposes two complementary approaches to screening, one using a novel extracellular vesicle-based assay that can be obtained rapidly and with very low blood volumes, and a second that modifies standard magnetic resonance imaging techniques to detect subtle evidence of focal fibroinflammatory changes in the pancreas, a common feature of pancreatic intraepithelial neoplasia, using a quantitative technique called magnetic resonance fingerprinting.